Mechanisms of Motor Neuron Injury in Acute Flaccid Myelitis

Project Summary/Abstract
Mechanisms of Motor Neuron Injury in Acute Flaccid Myelitis
Acute flaccid myelitis (AFM) is an infectious disorder of motor neurons that resembles poliomyelitis. AFM
predominantly affects children and has tragic consequences, often leading to lifelong paralysis. Concerningly,
the incidence of AFM has increased exponentially with each recent outbreak. Effective treatment options for
AFM are lacking, owing primarily to our poor understanding of disease pathogenesis. In the proposed work, I
will investigate mechanisms of motor neuron toxicity in AFM. The majority of cases of AFM are caused by
Enterovirus D68 (EV68). Therefore, I will focus on the infection of motor neurons by EV68 as a model of AFM.
First, I will evaluate the role of nucleocytoplasmic transport in motor neuron toxicity following EV68 infection.
This pathway is known to be altered in enterovirus infection and is also a key determinant of motor neuron
toxicity in neurodegenerative disease. I will further define the mechanism of disruption of the nuclear pore
complex by EV68, its effects on nucleocytoplasmic transport and motor neuron toxicity, and whether it can be
pharmacologically targeted to prevent motor neuron death in vitro. Second, to better define the pathologic
cascade following EV68 infection, I will investigate early pathologic events in a novel co-culture system
including motor neurons and muscle fibers. I will specifically investigate changes in motor neuron morphology,
electrophysiologic activity, and neuromuscular junction integrity. Third, I will determine whether host genetic
background influences EV68 infectivity or subsequent motor neuron toxicity by studying iPS motor neurons
derived from AFM patients compared to unrelated controls. Collectively, these studies will advance our
understanding of pathogenic mechanisms in EV68-associated AFM and evaluate putative therapeutic targets.
The experiments will also develop and refine model systems for the study of AFM and generate important
preliminary data for future studies leading to scientific independence. The training plan will provide new
training in virology methods and extend my expertise in iPS-based neurologic disease modeling and advanced
microscopy.

Public health relevance
Project Narrative Acute flaccid myelitis is an emerging infectious disorder caused primarily by Enterovirus D68 that resembles polio and is affecting increasing numbers of children in the Unites States and worldwide. It is poorly understood and therefore has few effective treatment options. To better define the pathophysiology of acute flaccid myelitis and evaluate therapeutic targets, I will study the infection of motor neurons by Enterovirus D68 to evaluate the role of disrupted nucleocytoplasmic transport in motor neuron toxicity, define early events in motor neuron pathology, and determine the role of host genetics in disease.